HIV CO-INFECTIONS IN UGANDA

Background: With the establishment and scale up of comprehensive HIV care programs in sub-
Saharan Africa (SSA) and the related reduction in mortality. There is an increasing number of
older people living with HIV (OPLWH). The scale up of ART has resulted in reduction in morbidity
and mortality with a subsequent increased longevity, by restoring the immune function following
suppression of viral load replication. However, despite this increased life expectancy, living long-
term with HIV and ART is associated with an earlier onset of clinical aging, chronic conditions
including geriatric syndromes in particular frailty, and neurocognitive impairment.
Aim: We plan to train a fellow in the research area of OPLWH as a steppingstone to the fellow’s
career development path, to the HIV-care and research program at IDI to build scalable tools for
care of OPLWH for HIV-care and research program, and pilot and evaluate a potential fellowship
program that can be scaled up in collaboration with the IDI to a full fellowship accredited by the
Makerere University.
Specific objectives 1. To train a research fellow to conduct research in OPLWH in Uganda. 2.
To adapt and validate instruments for geriatric assessment, specifically scalable screening tools
for frailty, physical function and sarcopenia for OPLWH in Uganda. 3.To evaluate the fellowship,
we will conduct a modified Kirkpatrick evaluation.
Methods: We plan to train a research fellow to conduct research in OPLWH with emphasis on
piloting and testing tools for clinical care of OPLWH focusing on frailty, physical and cognitive
function.
Additionally, the program proposes to adapt and validate instruments for geriatric assessment of
OPLWH, specifically scalable screening tools for frailty, physical function and sarcopenia for
OPLWH in Uganda. We will also will evaluate the feasibility of self-collection through tablets using
simplified validated tools for cognitive function, Quality of Life, Instrumental Activities of Daily
Living (IADL), history of falls, screening for depression, and incontinence.
Finally, to evaluate the fellowship, we will conduct a modified Kirkpatrick evaluation. Solicit
mentors ‘experience, lessons learnt and identify gaps that should be addressed in the planned
training program (D71 and D43 in research in HIV and geriatric medicine by Drs. Castelnuovo
and Byakika)

Public health relevance
The proposed program intends to: address the training gap in geriatric HIV research which can be incorporated as an accredited training at the College of Health Sciences, Makerere University; validate scalable tools to integrate comprehensive geriatric assessment into routine care for HIV-care and research programs of Older people living with HIV (OPLWH) in Uganda; pilot and evaluate a potential fellowship program in geriatric HIV research that can be scaled up in collaboration with the IDI to a full fellowship accredited by the Makerere University. This proposed fellowship evaluation will inform and provide preliminary data, identify gaps and document “lessons learnt” to inform future training grants D71 and D43 in research in HIV and geriatric medicine in OPLWH (HIV and geriatric medicine) accredited by the University and the curriculum for the School of Medicine.